FLUTICASONE PROPRIONATE 50 OR 100 MICROGRAMS BID VIA MULTIDOSE POWDER

This study will compare the efficacy and safety of two doses of a new inhaled corticosteroid, fluticasone proprionate (FP) usinf one of two delivery systems. Asthma is a potentially debilitating disease in children, likely accounting.